Decoding the Cellular Niches Critical for Lung Maturation and Pathogenesis

PROJECT SUMMARY
The human lung is vast organ with exquisite regional differences in the form of
cellular niches best defined at single-cell resolution. Emerging evidence led to growing
appreciation that the collective roles of these fine specializations are fundamental for
lung function. Guided by the scientific premise that these niches are often sites of
pathogenesis, we propose to map these niches in normal and disease tissues and
directly compare them at the single-cell resolution. This goal is directly responsive to the
mission of LungMap Phase 2 to “extend to more specific and rare cell types.”
To achieve this goal, we have gathered an interdisciplinary team of established and
rising, basic and clinical investigators with complementary strengths in developmental
biology (Sun), cell biology and immunology (Prince, Sajti), technology development and
informatics (Ren, Preissl, Wang and Xu). Together, we have a track record of studying
the control of normal lung maturation, as well as mechanisms underlying a number of
LungMap-highlighted diseases, including bronchopulmonary dysplasia, congenital
diaphragmatic hernia, childhood interstitial lung disease, and pediatric pulmonary
hypertension (PPH). We will use cutting-edge technologies such as single-nucleus
ATACseq, single-cell and single-nucleus RNAseq, multiplex antibody and RNA in situ
hybridization, and three-dimensional imaging. Using these, we will systematically define
the exciting kaleidoscope of cell types in the human lung, with an emphasis on cellular
niches that are central to pathogenesis.

Public health relevance
NARRATIVE The human lung is a vast organ with exquisite regional differences best defined at single-cell resolution. The goal of this study is to use cutting-edge genomic, epigenomic and imaging technologies to systematically define the exciting kaleidoscope of cell types in the whole lung, with an emphasis on cellular niches that are central to pathogenesis. We expect that our findings generated under the organization of the LungMap will serve as a powerful community resource, and advance our knowledge of lung maturation and pediatric lung diseases.